Adipocyte FGF1 Signaling in Systemic Metabolism

Project Summary/Abstract
Hyperlipidemia, characterized by elevated levels of lipids in the blood, causes significant abnormal metabolism
such as lipid accumulation, insulin resistance, mitochondrial dysfunction, and inflammation. These alterations
contribute to or are associated with various metabolic disorders, obesity, and diabetes, and become a leading
cause of atherosclerotic cardiovascular diseases (ASCVD). However, there is no compelling alternative to
replace conventional lipid-lowering therapies, which are still risky to many patients due to their associated
adverse effects. Therefore, developing more specific and efficient lipid-lowering therapies is essential. Fibroblast
growth factor 1 (FGF1) exhibits unexpected and potent glucose-lowering and insulin-sensitizing effects in
diabetic mice, leading to increasing attention to FGF1 in metabolic diseases. Nevertheless, the
pathophysiological roles of FGF1 in lipid homeostasis and atherogenesis remain unclear. Moreover, there is a
significant gap in the field regarding the underlying mechanism of FGF1 action on systemic metabolism. My
preliminary studies showed chronic administration of FGF1 and a non-mitogenic FGF1 variant (FGF1ΔHBS).
ameliorated atherosclerotic phenotypes associated with rectified hyperlipidemia, promoted insulin sensitivity,
and enhanced brown adipose tissue (BAT) activation in ApoEKO mice. Notably, FGF1 treatment accelerated the
plasma lipid clearance and distinctively enhanced lipid uptake in BAT, accompanied by significant increases in
lipoprotein lipase (LPL) activity and expression in BAT. My data further indicated brown adipocyte LPL-specific
deletion (LPLBAT-KO) abolishes FGF1’s benefits in lipid-lowering and glucose intolerance in ApoEKO mice.
Currently, activating BAT in adult humans has fueled substantial interest in exploring its potential as a ‘metabolic
sink’ in mice. The FGFR1 in adipose tissue is essential for FGF1’s anti-diabetic effects. These findings lead me
to central hypothesize that the FGF1/FGFR1 axis promotes LPL-mediated signaling in BAT to modulate systemic
metabolism and prevent atherosclerosis. Aim 1 will define BAT as a mediator for FGF1 effects on systemic lipid
homeostasis. Systematic assessment of the effects of FGF1 on lipid clearance and BAT activation in ApoEKO,
LDLRKO, and ApoEKO/LPLBAT-KO mice. FGF1 treated-BAT suppression and BAT ablation mouse models will be
subject to metabolic characterization. Aim 2 aims to determine whether brown adipocyte FGF1/FGFR1-LPL
plays a critical role in regulating metabolic homeostasis and preventing the progression of atherosclerosis. The
gain and/or loss of function of FGF1 will be investigated through BAT-specific FGF1 overexpression using the
AAV/Rec2-mADIPOQP-Fgf1 vector in ApoEKO/FGF1KO and brown adipocyte-specific FGFR1 knockout
(ApoEKO/Fgfr1BAT-KO) mice. These studies aim to uncover the mechanistic role of FGF1 in BAT in systemic
homeostasis. Additionally, brown adipocyte-specific knockout mice will be used to assess the clinical
translatability of FGF1ΔHBS in protecting against atherosclerosis. This proposed study will reveal that
FGF1/FGFR1-LPL signaling in BAT plays critical roles in modulating systemic metabolism, paving the way for
novel therapeutic strategies to address dyslipidemia-related metabolic diseases.

Public health relevance
Project Narrative FGF1 is a novel metabolic regulator in metabolic diseases, however, the underlying mechanism of FGF1's impact on adipose tissue towards systemic metabolism, remains unknown. Hyperlipidemia can cause various metabolic disorders and results in the prevalence of atherosclerotic cardiovascular diseases, with adipose tissue as a key in targeted interventions to reduce lipids in circulation and maintain systemic homeostasis in dyslipidemia. The goal of this study is to reveal new insight into adipocyte FGF1 signaling in lipid-lowering and systemic metabolic homeostasis, ultimately advancing the clinical translational potential of a novel non-mitogenic FGF1 variant (FGF1ΔHBS) as an innovative therapeutic strategy for atherosclerosis, and dyslipidemia associated-metabolic diseases.